Analysis of Lipolytic Trafficking in Adipocytes.

Project Summary/Abstract
Disruption of cellular neutral lipid metabolism promotes the progression of obesity, diabetes, fatty liver
disease, and cancer. The long-term scientific goal of the project is to understand the molecular mechanisms
that control lipid storage and mobilization in order to identify novel points for therapeutic intervention.
ABHD5 regulates cellular lipid metabolism, including PNPLA2/ATGL, the rate-limiting triglyceride lipase
in key metabolic tissues. Nonetheless, the mechanisms by which ABHD5, a protein lacking enzymatic activity,
activates PNPLA2 (and other PNPLAs) remains an important mystery.
We hypothesize that the remodeling of biological membranes is a general mechanism by which ABHD5
regulates enzyme access to membrane-delimited neutral lipid substrates. Mechanistically, we hypothesize that
ligand binding stabilizes ABHD5 molecular and macromolecular conformations that target and alter membrane
biophysical properties (tension and curvature) to allow the lipase access to specific substrates sequestered
within lipid droplets (LDs). We will test this hypothesis using novel chemical probes of ABHD5 and informative
genetic mutants in live adipocytes (Aim 1). We will directly assess the impact ABHD5 on the biophysical
properties of membranes in model LD systems using an array of high resolution and high throughput
approaches (Aim 2). These Aims are designed to be highly complementary and to provide strong cross-
validation between experimental platforms.
In addition, we present data demonstrating that ABHD5 is targeted to specific subcellular sites where
LDs form upon fatty acid supplementation. Furthermore, the interaction of ABHD5 with PLIN5, driven by the
ABHD5 ligand oleoyl-CoA, facilitates LD formation. Aim 3 will dissect the biochemical pathways promoted by
ABHD5/PLIN5 complexes and, in concert with Aim 2, evaluate the impact of this interaction on the biophysical
properties of model membranes.
ABHD5 is emerging as a compelling therapeutic target for metabolic diseases and cancer. The results
of this project will provide new insights into specific mechanisms by which ABHD5 regulates fatty acid flux at
the cytosol/LD interface.

Public health relevance
PROJECT NARRATIVE Understanding how cells store and mobilize lipids is an urgent scientific and therapeutic goal. This project addresses the molecular and biophysical mechanisms by which the protein ABHD5 regulates the mobilization and storage of lipids in cells. Understanding how ABHD5 can be targeted by synthetic compounds could lead to new therapies for diabetes, obesity, and cancer.